Probing conformational changes by protein surface azidation

SUMMARY: ADMINISTRATIVE SUPPLEMENT FOR EQUIPMENT (NOT-GM-24-021)
Funds are requested to purchase the Liberty PRIME 2.0 HT12 automated peptide synthesizer. The Adibekian
laboratory currently lacks an automated peptide synthesizer, necessitating the tedious manual synthesis of
shorter peptides using solid-phase synthesis. This equipment is vital for significantly enhancing our capacity to
synthesize longer probe peptides for ProSurA reactions, which are integral to our parent grant R01GM145886.
Systematically performing ProSurA reactions on synthetically pure, precisely defined 20+-mer peptides is
critical to understanding the chemical mechanism of the ProSurA reaction, as well as elucidating the impact of
specific amino acid sequences and secondary and tertiary structures on ProSurA reaction efficiency and rate.
Acquiring the Liberty PRIME automated synthesizer will significantly enhance our experimental capabilities and
accelerate our R01 research program, thereby advancing the mission of the NIGMS and NIH.

Public health relevance
NARRATIVE: ADMINISTRATIVE SUPPLEMENT FOR EQUIPMENT (NOT-GM-24-021) Funds are requested to purchase the Liberty PRIME 2.0 HT12 automated peptide synthesizer. The Adibekian laboratory currently lacks an automated peptide synthesizer, necessitating the tedious manual synthesis of shorter peptides using solid-phase synthesis. Acquiring the Liberty PRIME automated synthesizer will significantly enhance our experimental capabilities and accelerate our R01 research program, thereby advancing the mission of the NIGMS and NIH.